Cancer Research Training and Education Coordina

PROJECT SUMMARY – CANCER RESEARCH TRAINING AND EDUCATION COORDINATION
The Center for Cancer Mentoring, Education, Leadership, and Oncology-related Training (CAMELOT) serves as
the centralized hub for the Ohio State University Comprehensive Cancer Center (OSUCCC) fostering cancer
research and education, and disseminating those opportunities. CAMELOT’s efforts begin at the high school
level, continue through undergraduate and graduate training, and then extend through post-doctoral training and
into early faculty development and mentoring. CAMELOT is directed by Dr. Lawrence Kirschner, the OSUCCC
Associate Director of Training and Education. He is assisted by Drs. Deepa Sampath, Elizabeth Klein, and Rosa
Lapalombella. CAMELOT coordinates training and education programs through: 1) direct programs (e.g., for
high school, Pelotonia fellows, external undergraduate student summer rotations including students from Ohio
Historically Black Universities and Colleges); 2) integrating College of Medicine (COM) programs with OSUCCC
activities and opening them to trainees and junior faculty outside the COM; 3) supporting grant submissions by
junior faculty; and 4) supporting training grant submissions. The Pelotonia Fellowship Program (PFP), a major
commitment by the OSUCCC to fellowship training, has been in existence for 10 years, and provides stipends
and research support to fellows from the undergraduate to the postdoctoral fellowship level. OSUCCC provides
$2-3M/year to support the PFP. During the current grant cycle, 251 pre- and postdoctoral fellowships awarded,
of which 155 had mentors who were OSUCCC members from all five of the OSUCCC research programs and
10 of the 15 OSU Colleges. More than 90% of these trainees are currently active as cancer researchers. New
programs developed by CAMELOT include two cancer research-focused pipeline programs, one for local
underrepresented minority high school students and another for current OSU undergraduates. The Specific
Aims are to: 1) provide integration and coordination of training opportunities for cancer research across the
OSUCCC and university ecosystem, and region, including high schools and colleges; 2) enhance formalized
programming for cancer-based mentoring including both peer-to-peer and senior-to-junior mentoring; and, 3)
develop an integrated system to enable assessment and outcome tracking for trainees at all levels of
engagement with the OSUCCC (grants, papers, academic positions, etc.) to foster continuous quality
improvement in educational and career development activities. The OSUCCC is planning robust faculty
recruitment around strategic research priorities that will create new opportunities for education and training. To
accommodate this, a bigger pipeline for training is planned in the next funding cycle. The OSUCCC will: 1)
expand graduate and postgraduate training slots and programs for high school students; 2) establish the Young
Cancer Investigator Faculty Academy that focuses on OSUCCC wet-lab researchers to support development of
independent research programs; 3) establish a uniform tracking system for trainees; and 4) foster submissions
of R25 and T32 training grants, including supplements.